The contribution of lateral hypothalamus to cortical palatability coding and behavior

Project Summary
The central job of the taste system involves deciding whether a substance in the mouth should be swallowed or
rejected. This job is of unique importance, in that these decisions are necessarily made after a potentially toxic
stimulus is already internal. Primary gustatory cortex (GC) has proven vital for driving taste rejection behavior in
situ, but it is unlikely GC is acting alone to accomplish this task. Of particular interest as a possible functional
partner to GC is the lateral hypothalamus (LH), which has long been known to be centrally involved in feeding
behavior, and which contains neurons producing two distinct types of palatability-related taste responses. This
proposal describes work that will use multi-electrode electrophysiology, electromyography, pathway- and
neuron-specific optogenetics, and complex neural and behavioral analyses to investigate whether and how GC
and LH coordinate to drive consumption-related cortical firing and behavior. Dual-site electrophysiological
responses from awake, tasting rats will be analyzed to determine whether and how LH and GC responses are
coupled for production of palatability-related firing; further work will determine whether particular response types
or neurons (i.e., orexin+ neurons, known to drive consumption) contribute to any observed LH-GC coupling.
Perturbing LHGC input (and specifically the activity of orexin+ neurons) during tasting sessions will test whether
and how hypothalamic input impacts GC taste response dynamics. These experiments will be the first exploration
into GC-LH cooperation for taste processing and behavioral output. Over the course of this project, advanced
computational training will be acquired both in the classroom and through the development of novel scripts for
specific analyses. The collaborative and intimate environment within the lab and at Brandeis will nourish not only
the knowledgebase (computational and beyond), but the mentorship, communication, and technical skills
required to develop as an independent researcher. The combination of behavior, electrophysiology, and genetic
approaches will provide invaluable insight to the taste system, ultimately improving our knowledge of the
gustatory system and how taste processing and decisions are made. As we are directly investigating palatability
and its relationship to behavior this clears the path for future research on disorders related to consumption and
hedonics. As such, the work is related to improving human health in this era of obesity and binge-eating.

Public health relevance
Project Narrative The core pillars of this project are aimed at increasing our understanding of mammalian consumption behavior, the rejection of toxins, and the principles of sensory coding. As such, the work is directly related to improving human health in this era of obesity and binge-eating. Using electrophysiology in freely moving and consuming animals, along with pioneering computational techniques, I will examine the influence that the main feeding region, the lateral hypothalamus, has on cortical taste processing and behavior, paving the way for future research on intervention in disorders relating to hedonics and consumption.